Multi-target insect repellents for topical and spatial protection

ABSTRACT
Mosquitoes use their olfactory system to find human hosts and, in the process, can transmit diseases like
Malaria and Dengue to hundreds of millions of people worldwide that cause substantial mortality and
morbidity. The olfactory system therefore provides an excellent target to design behavior disruption strategies.
Most topical insect repellents in use (DEET, picaridin, IR3535) are effective against mosquitoes, however are
rarely used by the high risk population in tropical countries due to the cost relative to incomes, the
inconvenience of continuous application on skin at high concentrations and poor cosmetic properties. A more
commonly used method globally is the spatial protective effect from low dose pyrethroid insecticides emitted
from heated dispensers. However, the rapid spread of pyrethroid resistance in mosquitoes is cause for concern.
In a recent breakthrough we have been able to develop a Machine Learning cheminformatic method to predict
new repellent odorants and new pyrethroid-like molecules from in silico screening of >10 M compounds. In
validating them in behavior assays, we have identified several powerful repellents from natural sources
including compounds found in food and flavoring. In addition, we have identified a couple of leads for new
pyrethroids, which appear to be up as effective as allethrin at a 100 x lower concentration. The goal of this
proposal in 4 Aims is to identify the best-in-class insect repellent compounds and utilize them to create two
types of powerful broad-spectrum blends: a topical that protects for longer at a low concentration and a spatial
formulation that is more effective against knockdown resistant mosquitoes. For each blend we will also evaluate
a version which has a pyrethroid component. First, we plan to rigorously validate the computationally predicted
repellents in mosquito behavioral assays. Since the predictions have a variety of chemical structures, we will
also use behavioral analysis of extant mutants in Aedes aegypti to identify the underlying receptor pathways
responsible for aversion. Second, we plan to behaviorally evaluate volatile compounds that are known to
overstimulate and disable the CO2-recpetor for their ability to mask attraction spatially. Third, we propose to
validate the efficacy of the two newly discovered pyrethroids using topical and spatial assays. And fourth, we
will test the dual and triple aversive pathway compounds for repellency in mosquitoes to find the most effective
combination for spatial and topical repellency. Successful completion of this proposal will provide safe,
affordable, and pleasant-smelling odorants that are better than existing actives in reducing contact between
humans and mosquitoes.

Public health relevance
Mosquitoes transmit disease like malaria, Dengue, West Nile Fever and Yellow fever to hundreds of millions of people every year and are anticipated to remain a major global health problem due to a lack of vaccines, and lack of effective control methods for the vector. In this proposal we will identify behavioral repellents that will inhibit mosquito-human contact and can play an important role in controlling the spread of diseases if they were effective, affordable, and convenient for widespread use. Successful completion of this proposal will lead to identification of a new generation of broad-spectrum insect repellents that can block host-seeking mosquitoes from human contact.